Development of a 3D printed small animal intensity modulated radiation system

ABSTRACT
Animal models are the backbone of many areas of biomedical and preclinical research and the mouse is the
most used model organism in human disease research. Understanding and characterizing mouse models is
considered key to improving the reproducibility of preclinical results in human subjects. To this end it is
important to use preclinical techniques that are analogous to modern clinical techniques to increase the
success of results that translate well to clinical implementation. Unfortunately, the standardization of preclinical
radiation therapy (RT) studies using clinically analogous methodologies has not yet been achieved. In the last
few decades clinical RT technology has developed dramatically, with intensity modulated RT (IMRT)
representing one of the most significant developments. However, these advancements have not translated to
preclinical small animal RT, which largely resembles the state of clinical RT in the 1970s in terms of its use of
simple circular/rectangular beam geometries and uniform beam intensities, and lack of high-quality 3D target
dose conformality. Consequently, small animal RT studies do not simulate the radiobiological,
radioimmunological, hypoxic and toxicity environment of human therapies. To fully standardize preclinical
irradiators to clinically analogous methodologies it is necessary to fully implement IMRT. However, reverse
translation of IMRT from a clinical to preclinical scale (1-2 orders of magnitude smaller) has been challenging
due to technical limitations in engineering appropriately small multi-leaf collimators (MLC).
Our group has recently developed a 3D printed compensator (3DPC) approach that provides a simple,
reliable, and cost-effective solution in implementing mouse based IMRT. In terms of simplicity and cost-
effectiveness, 3DPC-IMRT requires no additional specialized equipment besides an inexpensive commercially
available 3D printer and printing material. Unlike MLC systems, 3DPC-IMRT has no segments/steps during
delivery leading to shorter treatment times and no mechanical/electrical parts leading to high reliability, lower
maintenance, and reduced QA efforts. Our central hypothesis is that we can develop 3DPC-IMRT into a high-
throughput preclinically useful small animal IMRT system using AI assisted contouring, novel high speed dose
calculation and optimization algorithms, and a mechanism that will allow rapid switching of compensators for
different fields. We propose the following specific aims: (1) Design and development of 3D printed
compensator IMRT (3DPC-IMRT), (2) Development of VMAT like 3DPC-IMRT and AI mouse segmentation
methods, and (3) Dosimetric accuracy evaluation and pancreatic ductal adenocarcinoma (PDAC) mouse
model study. The success of the proposed project will help radiation biology research better simulate the
clinical RT environment and enable future studies where accurate complex dose distributions are critical.

Public health relevance
NARRATIVE In the last few decades clinical radiation therapy (RT) technology has developed dramatically, with intensity modulated RT (IMRT) representing one of the most significant advances, however, these advancements have not translated to preclinical small animal RT, which largely resembles the state of clinical RT in the 1970s in terms of its use of simple circular/rectangular beam geometries, uniform beam intensities, and lack of high quality 3D target dose conformality. Consequently, small animal RT studies do not allow for accurate 3D dose targeting or simulate the radiobiological, radioimmunological, hypoxic and toxicity environment of modern human RT. The goal of this proposed project is to create a novel 3D printed compensator IMRT (3DPC-IMRT) system that is low cost, easy to implement, and can allow high mouse throughput.